Salmonella-specific Th1 cell function and residence

Typhoid and Non-Typhoidal Salmonellosis (NTS) are systemic diseases that annually cause 1 million global
deaths. Greater understanding of protective immunity to Salmonella will be required if safe and effective
vaccines for these diseases are to become a reality. Our application examines the fundamental biology of
protective CD4 Th1 cells elicited by live vaccines that provide robust protective immunity. Our experimental
approach is unique in that it utilizes natural water contamination challenge, uses a mouse model where CD4
Th1 cells participate actively in bacterial clearance, and allows for direct visualization of endogenous
Salmonella-specific CD4 T cells, using reagents recently developed by our laboratory. Our application
specifically proposes to, (i) examine the role of non-cognate Th1 cell stimulation in Salmonella clearance, (ii)
determine the role of tissue-resident memory cells in the elimination of persistent bacteria, and (iii) examine
whether these two functional aspects of Th1 cell memory can be induced by a sub-unit immunization strategy.
Understanding these issues will increase our knowledge of Salmonella-specific CD4 Th1 cell biology and could
be vital for the development of safe and effective vaccines for typhoid and NTS.

Public health relevance
Systemic Salmonella infections are responsible for almost 1 million deaths annually and there is an urgent need to understand the mechanisms of protective immunity. Host CD4 T cells responses are critical for protective immunity to Salmonella in humans and in mouse models but there is a knowledge gap in relation to the functional requirements for memory CD4 T cells during a protective response. This application will examine two functional aspects of protective Salmonella-specific CD4 T cells in an attempt to understand why some immunization strategies succeed and others fail to protect against infection.